Deciphering respiratory disease mechanisms through integration of genomic and functional data across massive global biobanks

PROJECT ABSTRACT/SUMMARY
Chronic obstructive pulmonary disease (COPD) and asthma are the two most common chronic respiratory
diseases, with COPD as the third leading cause of death globally and asthma as the most common chronic
disease of childhood. They are treatable, heritable, strongly affected by the environment (e.g. smoking, pollution),
and exhibit some of the largest disparities in prevalence and survival among populations. Genetic and multi-omic
technologies provide powerful opportunities to identify both shared and distinct heritable risk factors among
asthma and COPD, connect those genetic variants with function, and delineate relationships between genetic,
environment, and disease risk using multi-omic molecular assays. However, most genetic studies of lung
diseases and comorbid traits to date have focused narrowly on one or few traits at a time without modeling the
dense correlation between risk factors and have been vastly Eurocentric. This is problematic, as minority
communities who face a higher burden of respiratory diseases disproportionately experience adverse exposures
that can be challenging to study because they are often imprecisely measured, and the level of exposure that is
biologically meaningful for disease onset and progression is unclear.
In this R01 application, we will integrate multi-trait, multi-ancestry, and multi-omic data from massive biobanks.
We will bring together genetic and phenotypic data across the All of Us Research Program, Million Veterans
Program, UK Biobank, FinnGen, and other global biobanks, totaling more than 2 million participants, including
approximately 240,000 COPD cases, 260,000 asthma cases, and 60,000 proteomic profiles. In Aim 1, we will
conduct powerful genetic studies of lung diseases and comorbidities, model genetic correlations among related
traits and ancestries to maximize genomic discovery, refine putative causal variants, and predict genetic risk
accurately across populations. In Aim 2, we will connect asthma and COPD genetic risk loci to function by using
their pleiotropic relationships to dissect them into sets with similar effects, then test for enrichments and
colocalizations among these sets of variants with multi-omic molecular assays to elucidate their molecular
mechanisms. Lastly, in Aim 3, we will bridge the gap between inherited and environmental influences to better
understand phenotypic heterogeneity in asthma and COPD by leveraging proteomic and metabolomic profiles
to develop scores that predict incident disease and well-known risk factors.
This R01 application will deliver accurate and reproducible genetic, environmental, and multi-omic molecular
predictors of asthma and COPD that will identify causal mechanisms and modifiable risk factors. Quantifying the
relative importance of risk factors as proposed here is critical for advancing clinical models, nominating targeted
interventions to improve public health, and ultimately reducing vast health disparities in lung disease.

Public health relevance
PROJECT NARRATIVE The two most common respiratory diseases, chronic obstructive pulmonary disease (COPD) and asthma, exhibit some of the largest disparities in prevalence and survival among populations, with COPD as the third leading cause of death globally, and asthma as the most common chronic disease of childhood. These diseases are complex, arising from a multitude of genetic and environmental risk factors which partially overlap between diseases. In global biobanks, we will conduct massive genetic studies associating variants across the allele frequency spectrum with asthma, COPD, and comorbid traits and diseases to identify inherited risk increasing loci, which will facilitate dissection of their heterogeneous molecular etiologies, development of accurate and generalizable genetic risk predictors, and development of multi-omic predictors which we will use to investigate subtypes, exacerbations, and disease progression.